Peripheral Biomarkers for Early Diagnosis of Mixed Pathologies in AD/ADRD

The overall goal of our proposed research is to develop robust premortem biomarkers for accurate and
differential diagnosis of Alzheimer's disease (AD), non-AD tauopathies, Lewy body dementia (LBD), and their
comorbidities. A pathological hallmark of AD and other tauopathies is the deposition of tau protein aggregates
in the brain, whereas in LBD there is accumulation of α-synuclein (aSyn) aggregates. Strikingly, more than half
of patients with clinically diagnosed AD or LBD have concomitant tau and aSyn co-pathologies at autopsy.
Moreover, patients with mixed tau and aSyn pathologies often suffer from worse clinical outcomes. Currently, it
is highly challenging to clinically differentiate AD, LBD, and mixed AD/LBD due to overlapping symptoms.
Moreover, co-existence of aSyn pathology also occurs frequently in non-AD tauopathies. Recent advances in
brain imaging and immunoassays of amyloid-β and phosphorylated tau (p-tau) have greatly facilitated diagnosis
of typical AD. However, these assays fail to identify non-AD tauopathies and mixed AD/LBD. Therefore,
alternative measures in easily accessible biospecimens are warranted, especially if they enable simultaneous
detection of tau and aSyn aggregates in patients with mixed tauopathies and synucleinopathies. In preliminary
studies, we have leveraged the newly emerged technology known as the real-time quaking-induced conversion
assay (tau RT-QuIC) for specific detection of tau aggregates in the skin of patients with AD and non-AD
tauopathies. In conjunction with recently established aSyn RT-QuIC, we are in a unique position to accurately
diagnose patients with mixed tau and aSyn pathologies using easily accessible skin specimens. We hypothesize
that skin tau and aSyn detected by RT-QuIC are novel biomarkers for early and differential diagnosis of
mixed tauopathies/synucleinopathies in routine clinical practice. We propose to test this hypothesis by
pursuing three Aims: 1) Establish dual skin RT-QuIC biomarker assays for mixed tauopathies/synucleinopathies
using neuropathologically confirmed cases; 2) Assess skin tau and aSyn detected by RT-QuIC as reliable
biomarkers for premortem diagnosis of mixed tauopathies and synucleinopathies; and 3) Evaluate skin tau/aSyn
biomarker assays for improving the differential diagnosis of mixed tauopathies/synucleinopathies through
longitudinal follow-up. This translational project is supported by rich clinical resources and a strong team of basic
and clinical neuroscientists. The successful outcome of our proposal will establish a robust skin-based diagnostic
test for mixed pathologies that is prevalent in AD and related dementias, thus facilitating better patient care and
development of disease-modifying therapies.

Public health relevance
Project Narrative The overall goal of our project is to validate diagnostic tools for Alzheimer’s disease and related dementias such as tauopathies, Lewy body dementia, and their comorbidities affecting millions of people in the U.S. Our study may ultimately help early diagnosis to improve patient care and aid the development of therapeutics for patients living with dementias.